Nationwide examination of access to comprehensive care in sickle cell disease

PROJECT SUMMARY
Sickle cell disease (SCD) is a complex and highly morbid inherited blood disorder that affects at least 100,000
people in the US. It is associated with a 20-year reduction in life expectancy and substantial economic costs to
the health care system. Research and clinical care for SCD has faced challenges from a lack of population-
level registry data and a historic paucity of specialist care relative to comparator inherited diseases like
hemophilia or cystic fibrosis. Recent years have seen an increased focus on the development of
comprehensive sickle cell centers (CSCCs); however, we do not know how many people with SCD have
access to CSCCs at a population level, nor do we know the impact of receiving care at these centers on
health-related outcomes.
To address these gaps in knowledge, we propose two analytic aims using national insurance claims data from
Medicaid, which insures the majority of people with SCD in the US. In the first aim, we will identify three groups
of people with SCD: those who A) do not receive care from a hematology provider, B) receive care from a
hematology provider but not at a CSCC, and C) receive health care at a CSCC, and we will identify
sociodemographic characteristics associated with not receiving care at a CSCC. The second aim will use an
econometric approach called instrumental variable (IV) analysis, which is a quasi-experimental design that
accounts for bias in observational data to produce estimates of causal effect. We will use IV analysis to
estimate the causal effect of receiving care at a CSCC on mortality and health care utilization, using differential
distance to a CSCC as an instrument.
The proposed research will provide the first national description of access to comprehensive care for people
with SCD and the most robust estimate of the impact of receiving comprehensive care to date. These results
will help health care providers consider the role of CSCCs for people with SCD, and they will inform
policymakers’ discussions about allocation of resources toward comprehensive care in SCD. This work will
also provide critical training to the applicant in the form of mentorship in SCD and advanced research
methodology as he pursues his goal of becoming an independent health services researcher in SCD.

Public health relevance
PROJECT NARRATIVE Sickle cell disease is a complex and highly morbid inherited blood disorder, and quality health care for sickle cell disease requires expertise and extensive health care resources. The objective of this study is to examine access to comprehensive care for people with sickle cell disease across the country and to estimate the impact of receiving comprehensive care on mortality and health care utilization. This research will be useful in planning the role of comprehensive care centers for sickle cell disease in the health care system and identifying populations that may benefit from improved access to comprehensive care.